Deciphering protein ubiquitination with chemical biology tools

Ubiquitination as a reversible post-translational modification is essential to a broad range of cellular
processes in humans. In addition to its function in proteasome-mediated protein degradation, ubiquitination is
crucial for many non-proteolytic cellular processes. These cellular processes are regulated by a diverse array of
polyubiquitin chains of different linkages and topologies, including recently discovered branched polyubiquitin
chains. Deubiquitinases (DUBs) modulate the ubiquitin chain linkage and structure and are considered promising
new targets for therapeutic intervention. The goals of our work are to investigate the recognition and cleavage
of atypical polyubiquitin chains and ubiquitinated proteins by DUBs; identify and characterize reader proteins of
branched ubiquitin chains and understand the roles of branched ubiquitin chains in mitophagy and receptor
endocytosis. These projects are interconnected and complementary to each other, building on our success in
chemical protein ubiquitination and DUB probe construction using semisynthetic approaches. The new chemical
biology tools developed, particularly novel activity-based DUB probes, will serve to unveil new biological targets
and functions in the ubiquitin system and provide new ways of identifying the reader and eraser proteins of
ubiquitin signals. The mechanistic and structural insights obtained will in turn propel drug discovery efforts
exploiting the ubiquitin system and lead to new opportunities and means for treating human diseases including
neurodegeneration and cancer.

Public health relevance
Narrative The ubiquitin proteasome system is currently underexploited for therapeutic interventions despite a vast number of proteins and complexes associated with this vital system. Our understanding of ubiquitin signaling mechanisms as mediated by the many forms of ubiquitin modifications is still lacking. Chemical tools are central to the efforts in unraveling the complex pathways and mechanisms in ubiquitin signaling and they also provide new ways of exploiting the ubiquitin pathway enzymes for drug development, thus achieving therapeutic benefit in treating human diseases such as neurodegeneration and cancer.